University of Illinois at Chicago KPMP CKD Recruitment Site

Chronic kidney disease (CKD) is a major public health problem in the United States that affects 37 million
Americans and disproportionately burdens racial and ethnic minority populations. Advances in personalized
medicine approaches for patients with CKD lag behind advances in other fields. Current approaches to
classifying CKD do not provide granular insight into the underlying mechanisms that contribute to the
heterogeneity of the disease. To address this gap, NIDDK established the Kidney Precision Medicine Project
(KPMP) in 2016 with the overarching goal of using deep molecular phenotypes of kidney biopsies, along with
longitudinal clinical phenotypic data to develop new disease ontologies and treatments for kidney disease. This
proposal for a University of Illinois at Chicago (UIC) KPMP CKD Recruitment Site brings together a diverse
multidisciplinary team of experienced investigators with expertise in nephrology, renal pathology, interventional
radiology, bioethics, social determinants of health, and biostatistics. Our team has a successful track record in
recruiting and retaining large and diverse populations of patients with CKD in long-term studies. This proposal
has three overarching goals: 1) Utilize our well-established and successful recruitment strategies to enroll 100
participants (50% non-Hispanic Black, 30% Hispanic) from the University of Illinois Health Science System and
a large affiliated federally qualified health center to undergo high-quality research kidney biopsies, conforming
to the highest ethical, research and clinical standards; 2) Leverage the infrastructure of the UIC Chronic Renal
Insufficiency Cohort (CRIC) Study Clinical Center to enroll 50 eligible CRIC participants into KPMP, providing
an unprecedented opportunity to link data from this deeply phenotyped cohort with KPMP kidney biopsy
measures; and 3) Implement a systematic assessment of neighborhood-level measures of social determinants
of health which will advance the overall mission of KPMP to better characterize disease subgroups. We will
use an established real-time electronic health record-based reporting system to identify eligible individuals in
the two health care systems and then engage potential participants in an open discussion of the risks and
benefits of a research kidney biopsy. Additionally, we will utilize patient-centered strategies to maintain long-
term patient engagement and achieve high rates of retention with the guidance of a local Community Advisory
Board composed of key stakeholders (i.e., patients, a caretaker, and a primary care provider). Leveraging our
expertise and experience working with NIDDK U01 cooperative projects, we will rapidly and effectively
implement the KPMP protocol, work collaboratively with the consortium, and will make substantial contributions
to the long-term scientific mission of KPMP to develop precision medicine-based approaches for treating
kidney disease.

Public health relevance
Even though chronic kidney disease (CKD) affects nearly 40 million Americans, advances in the treatment of CKD lag behind advances in the treatment of other diseases. The Kidney Precision Medicine Project (KPMP) aims to reduce the burden of CKD by facilitating the development of precision medicine approaches for the treatment and prevention of CKD. The University of Illinois at Chicago KPMP CKD Recruitment Site research team will make significant contributions to the operational and scientific missions of KPMP by accomplishing the following goals: 1) enroll a diverse cohort of 150 adults with CKD to undergo a research kidney biopsy and longitudinal follow-up and 2) implement a systematic evaluation of neighborhood-level measures of social determinants of health which will advance the long-term mission of KPMP to deeply characterize disease subgroups.